Development of selective HDAC6 inhibitors to improve cancer immunotherapy

Project Summary
The median survival for metastatic melanoma is approximately 8–16 months, and few therapies offer a
significant improvement in overall survival. However, immunotherapeutic strategies that abrogate immunologic
checkpoints or improve immunosurveillance have shown promise, especially in melanoma.
We have found that both genetic abrogation and pharmacologic inhibition of HDAC6 leads to a
decreased infiltration of pro-tumoral tumor-associated macrophages and downregulation of
immunosuppressive mediators. These effects translated into a pronounced delay of in vivo melanoma tumor
growth, which is, at least in part, dependent on intact immunity, as evidenced by the restoration of tumor
growth after CD4+ and CD8+ depletion. Our findings demonstrate a significant immunoregulatory role of
HDAC6 in melanoma, providing a rationale for the use of selective HDAC6is to improve antitumor immunity.
We are most interested in identifying HDAC6is that are best able to reduce the pro-tumoral phenotype of
tumor-associated macrophages and decrease the expression of immunosuppressive surface molecules such
as PD-L1 and PD-L2 while showing little cytotoxicity on their own.
Our goal is thus to design, synthesize, and test new HDAC6i both in vitro and in vivo for use in the
treatment of melanoma and other malignancies. The aims to be accomplished under this grant are as follows:
1. Using molecular modeling, design, and synthesize ~50 new HDAC6is per year, for the first three years and
test these for HDAC isozyme selectivity; the last two years of the grant will focus on compound scale-up,
preclinical translational studies, and advanced ADMET testing.
2. Evaluate compounds that have IC50 values of <50nM and at least 400-fold HDAC6 selectivity using in vitro
melanoma models to measure acetylated tubulin, pSTAT3, PD-L1 levels, and cytotoxicity. For compounds
found to decrease levels of pSTAT3 and PD-L1, while increasing acetylated tubulin, conduct early-stage
ADMET studies (2 – 3/year) using a CRO, and if needed, modify the compounds using principles of medicinal
chemistry and molecular modeling based methods to increase the compound’s drug-like character.
3. Lastly, test the best compounds for their ability to delay tumor growth in syngeneic murine melanoma
models, both as stand-alone and in combination with PD-1 blocking antibodies. Additionally, we will evaluate
our best candidates using humanized PDX models and as a cell therapy pre-treating macrophages to avoid
their switch to M2-like protumoral phenotype. Those candidates showing the best in vivo efficacy will be sent
for advanced ADMET, including chronic toxicity studies, cardiac activity, and pulmonary activity in rats.
Our proposed work is significant as it helps to fill this critical knowledge gap and thus moves epigenetic-
based combination immunotherapies to a new level. The concept to be validated is novel as it significantly
deviates from the classical cytotoxic role of HDAC inhibitors as anti-cancer agents.

Public health relevance
Project Narrative The quest for newer and more effective ways of treating cancer has now led to an extensive focus on the involvement of the immune system and its capacity to recognize and engage tumor cells. In the proposed research we plan to improve the therapeutic efficacy of several known HDAC6 inhibitors (HDAC6i) in order to identify drug-like compounds that are best able to reduce the expression of negative immune check-point molecules. We believe that this HDAC approach will allow for the restoration of immune surveillance mechanisms in cancer cells, especially when the HDAC6i are combined with immunotherapeutic agents such as anti-PD-1 blocking antibodies, thereby leading to improved anti-tumor immune responses.